RFA-DP-21-001 DP006602 PUERTO RICO PREGNANCY RISK ASSESSMENT MONITORING SYSTEM COMPONENT A: CORE SURVEILLANCE

PUERTO RICO PREGNANCY RISK ASSESSMENT MONITORING SYSTEM (PR-PRAMS):
COMPONENT A CORE SURVEILLANCE
The major goal of PR-PRAMS is to collect data representative of PR’s population on health status,
maternal attitudes, behaviors and experiences that occur prior to, during, and after pregnancy, in
order to reduce maternal and infant morbidity and mortality. This will allow for informed decision
making, resource allocation, policies, and systems changes that support effective programming
of services for women and infants, resulting in public health impact and improvements in
population health. The study objectives are: 1) To implement population-based surveillance in
PR on selected maternal behaviors and experiences that occur prior to, during, and shortly after
pregnancy among women with a recent live birth, including emerging issues and post-disaster
surveillance needs, as they arise; 2) To ensure data is of high scientific quality and comparable
to other jurisdictions by following the methodology documented in the CDC PRAMS protocol; 3)
To conduct comprehensive analysis of PR-PRAMS data based on an analysis plan designed to
inform programmatic activities, research and implement public health practices in PR; 4) To
translate and disseminate research analytic results into practical and useful information for public
health action in PR that can guide program development and evaluation, in collaboration with the
PR-PRAMS Steering Committee (SC). PR-PRAMS will follow a standardized data collection
methodology that allows for comparisons with other states and for optimal use of the data for
single-state analysis. The survey will include core, standard and state developed questions,
according to gaps in data identified for PR. PR-PRAMS methodology combines two modes of
data collection: a mailed questionnaire and telephone interviews with follow-up attempts. Each
month, a stratified sample is drawn from the Vital Statistics (VS) data file and the sequence of
contacts is attempted. A questionnaire will be mailed 2 to 4 months to sample selected women
who have recently delivered live born infants. The data collection cycle takes 60 to 95 days.
PR-PRAMS has been implemented since 2016. During the first four (4) years of implementation
of the cooperative agreement, PR-PRAMS has met all its goals and objectives. Staff is already
in place to continue operations. The project’s infrastructure is operating efficiently, reaching a
63% response rate in 2017, 80% in 2018 and 81% in 2019. A SC is organized to continue
providing input on questions selection, development of State Analysis Plan (SAP) and translation
and dissemination of data. PR-PRAMS data is being used to monitor PR national performance
objectives for Title V block, and has served to benchmark select performance measures to
demonstrate the impacts of Title V on health outcomes. The data collected is also used to support
emerging issues and other priorities in Maternal and Child Health (MCH), and to evaluate and
sustain public health efforts, develop plans, and training. Data is being disseminated through
different forums to a variety of stakeholders to raise awareness on maternal and child health
issues. The expected outcomes of the survey are: 1) Produce timely, high quality data
representative of the jurisdiction’s population to monitor risk factors for maternal and infant health;
2) Analyze and disseminate PRAMS data on a variety of MCH topics to inform public health
programs, research and system changes, and health care system changes; 3) Document efforts
to translate data into useable information for public health action; 4) Make PRAMS data available
to stakeholders including public health agencies, clinical providers, health systems, and
researchers for studies to inform knowledge gaps in maternal and infant health.

Public health relevance
Puerto Rico Pregnancy Risk Assessment Monitoring System: Core Component A Project Narrative The accurate and continuous data obtained from PR-PRAMS will fill in information gaps. The data gathered on the morbidity of women before and during pregnancy is important to ascertain the factors influencing positive and/or adverse pregnancy outcomes. This will allow for informed decision making, resource allocation, policies, and systems changes that support effective programming of services for women and infants, resulting in public health impact and improvements in population health.